Project 3-Characterizing the contribution of autoantibodies to liver damage in alcoholic hepatitis

Severe alcoholic hepatitis (SAH) is the most severe form of the alcoholic liver diseases (ALD) caused by acute
and chronic alcohol abuse. ALD is associated with increased susceptibility to pneumonia, viral infections (e.g.,
HIV and HCV), and infection with Mycobacterium tuberculosis. Current therapies are largely ineffective – 40% of
patients do not respond to corticosteroid therapy with high resultant short term mortality. Therefore, the
development of novel targeted therapies will be dependent on delineating the molecular mechanisms of SAH.
Studies in the past thirty years in both humans and animal models have revealed that acute and chronic alcohol
consumption cause leaky gut via inflammation, gut microbiome dysbiosis, tight junction disruption, decreased
mucus and antimicrobial peptides. The advance of bacterial 16S rRNA revealed that in alcoholics with dysbiosis
Bacteroidacea have been found to be decreased while Proteobacteria and Fusobacteria were increased. It is
now clear that a gut-liver axis is causatively linked to progression of alcohol-induced liver disease. Our long-term
goal is to identify novel therapeutic targets and develop novel therapy for intervention and prevention of SAH.
During the current funding period, the Zhu and Sun groups discovered a massive deposition of antibodies in
SAH livers, and that these antibodies exhibited hepatocyte killing efficacy, while the corresponding serum
antibodies did not. We further showed that antibodies from SAH livers cross-react with both human and E. coli
proteins. Finally, large amounts of B and plasma cells are found infiltrating SAH livers. Based on these results
and the literature, we hypothesize that B and plasma cells infiltrated in SAH livers produce anti-gut bacteria
antibodies that can cross-react with human proteins and cause liver damage. Identification of the origin of gut
bacteria that elicit the cross-reacting antibodies in SAH is a crucial step towards understanding the etiology of
SAH. Equally important is to isolate the B and plasma cells infiltrated in SAH livers and characterize their roles in
liver damage. The goal of this proposal is to determine the origins of these cross-reacting antibodies in SAH and
characterize their function and contribution to liver damage. To test our hypothesis, we propose three Specific
Aims: 1) Identify gut bacteria that elicit cross-reactive antibodies specific in patients with SAH; 2) Determine
cross-reactive antibody signatures in patients with SAH; and 3) Characterize B/plasma cells infiltrated in SAH
livers that produce cross-reactive antibodies. The success of this project will allow us to further elucidate the
molecular mechanism of the gut-liver axis in liver injury.

Public health relevance
Project Narrative Severe alcoholic hepatitis (SAH), an acute presentation of alcoholic liver disease (ALD), carries an extremely high mortality rate and early liver transplantation (ELT) is the only life-saving option available for patients who are refractory to medical management. We have established the largest cohort of ELT recipients in the world and preliminary investigations have shown promising short-term outcomes for individuals who undergo ELT and given us considerable insight into the pathophysiology of ALD. The insight provided by the studies described in the projects that comprise our ALD research initiative will be integral for guiding the expansion of ELT and the ethical framework developed will help influence the creation of a national policy governing the practice.